Clinical Pharmacology Training Program

7. Project Summary
The Clinical Pharmacology Training Program at Johns Hopkins is designed to train highly-qualified physicians,
pharmacists, and scientists to become independent clinical investigators applying the tools of clinical
pharmacology to advance drugs from the laboratory to the clinical treatment and prevention of disease in
people. This program addresses a critical shortage of well-trained clinical investigators who conduct hands-on
studies in humans, particularly in the area of clinical pharmacology. The program is centered in the Division of
Clinical Pharmacology, which is jointly within the Department of Medicine and the Department of
Pharmacology and Molecular Sciences, in the School of Medicine. This venue is ideal for conducting research
that translates basic molecular discoveries into clinical trials. The training program takes three to four years to
complete and includes a core curriculum in clinical pharmacology (coursework, conferences, experiential
rotations, and research) as well as matriculation, typically, in the Graduate Training Program in Clinical
Investigation in the School of Public Health. In keeping with the collective expertise of the Division faculty,
research commonly focuses on anti-infective drugs, and has been expanded to include oncology, pediatrics,
pharmacoepidemiology, and obstetrics and gynecology, among other areas. Each trainee has a mentoring
team who oversees the fellow’s progress in the principles and analytical disciplines of clinical pharmacology,
clinical research, and professional development. Participating faculty are carefully chosen and committed to
playing a critical mentoring role for the fellows. Although there are no clinical care responsibilities in the
program apart from clinical research, fellows may complete a concurrent clinical subspecialty fellowship. The
program solicits and receives the regular advice of an External Advisory Board comprised of distinguished
translational- or clinician-scientists and outstanding clinical pharmacology educators from within and outside of
Johns Hopkins. After completion of this rigorous, comprehensive, and nurturing program, most graduates have
achieved board eligibility in Clinical Pharmacology, board eligibility in a medical sub-specialty clinical area
(MDs), and a PhD or MHS in Clinical Investigation. Historically, most of our graduates step directly into
academic research careers as Assistant Professors, at the interface of basic and clinical pharmacology.

Public health relevance
8. Project Narrative This program trains physicians, pharmacists, and scientists in the principles and practice of Clinical Pharmacology, a branch of science that focuses on the study of drugs in humans and brings basic lab discoveries into clinical practice. In a three to four-year program, trainees have rigorous in-class education and will conduct clinical studies of drugs in humans.